Novel growth factors and regenerative RGC subtypes for optic nerve regeneration

Project Abstract or Summary
Following injury to the optic nerve in mammals, retinal ganglion cells (RGCs) cannot regenerate their axons and
soon undergo apoptotic cell death, leading to permanent vision loss. Some degree of optic nerve regeneration
can be induced experimentally but the extent of regeneration achieved to date remains away from the level of
visual functional recovery required, pointing to the need for more effective therapies. Aside from testing well
established growth factors and chance discoveries of several novel factors, a more systematic screening of as
yet untested ligands to the many trophic factor and chemokine receptors that are expressed in adult RGCs could
augment regeneration well beyond currently achievable levels. In recent genetic studies (RNA-Seq, FACS-
purified cells), we have obtained an extensive list of growth factor, chemokine and peptide receptors that are
expressed in adult RGCs, many of whose ligands have not been tested for effects on axon regeneration and
RGC protection. To carry out the screening, we will use an adult RGC culture system and in vivo optic nerve
regeneration models that have been used on our lab for 2 decades, and which have enabled us identify three
previously unknown potent factors for optic nerve regeneration. The proposed studies will screen the ligands to
the multiple receptors that are expressed in adult RGCs to discover novel factors for optic nerve regeneration
and RGC survival. With significantly improved automated cell culture system, Aim 1 will carry out an in vitro
bioactivity screen and verify hits in vivo, respectively. Aim 2 will screen which subtypes of RGCs are responding
to the known effective treatments and the new hits from Aim 1. This will enable us develop combinatorial
treatments to stimulate axon regeneration from multiple RGC subtypes simultaneously. Through these studies,
we expect to promote considerably greater levels of axon growth than can be attained currently and ultimately
bring us closer to improving visual function after optic nerve damage.

Public health relevance
Project Narrative Mammalian retinal ganglion cells (RGCs), the neurons that convey information from the eye to the brain, cannot regenerate their axons once the optic nerve is injured, resulting in permanent vision loss. Some degree of optic nerve regeneration has been achieved in the past, but the extent of regeneration remains far from a level needed for significant visual recovery, pointing to the need for more effective therapies. Based on our recent transcriptome-based analysis of receptors for trophic factors, chemokines, and peptides that are expressed in adult RGCs, I will carry out a systematic bio-activity screening in vitro and in vivo to identify novel growth- and survival factors, followed by a complementary study to identify the responsive RGC subtypes, with the goal of discovering novel growth- and pro-survival factors to enable multiple RGC subtypes to survive injury and extend lengthy axons, potentially augmenting optic nerve regeneration well beyond currently achievable levels.